GASTRIC ASPIRATE FOR DIAGNOSIS OF PEDIATRIC TB

Compare two clinical practice methods of collecting gastric aspirates for the diagnosis of suspected tuberculosis in children and compare several laboratory methods for identifying M.tuberculosis complex in the specimens.